Compromised LDH activity causes motor deficits and hastens ALS progression

Motor axon loss is a cardinal symptom of motor neuron disorders including amyotrophic lateral sclerosis
(ALS). Schwann cells (SCs) myelinate and provide trophic support to axons in the peripheral nervous system
(PNS) and disruption of SC metabolism often leads to axon degeneration, both symptoms of peripheral
neuropathy. The lactate shuttle hypothesis proposes that glycolytic glial support cells supply lactate to axons to
sustain their high metabolic demands, a process that requires interconversion of lactate and pyruvate via lactate
dehydrogenase (LDH) in both glia and neurons. To test this hypothesis in the PNS, we deleted LDH subunits
LDHA and LDHB specifically in motor neurons (MNs), sensory neurons (SNs), or SCs. We find that LDH deletion
in SCs or MNs leads to progressive degeneration of motor axons, whereas LDH loss in SNs causes no apparent
abnormalities in sensory axons. These results support a model in which lactate shuttling from SCs selectively
sustains motor but not sensory axons and suggest that LDH activity and lactate shuttling play a role in motor-
dominated neuropathies such as ALS. Indeed, LDHB-deficient mice develop progressive motor dysfunction
similar to ALS mouse models, and LDH deficiency synergizes with a slowly progressing ALS model to induce
severe, early onset disease. In conjunction with these studies, we identified rare loss-of-function LDHB mutations
in ALS patients.
In this proposal, we outline experiments to examine the differential responses of MN and SN neurons to
loss of LDH function to identify pathways involved in the observed selective motor axon degeneration. We will
use a cellular complementation assay utilizing iPSC-derived neurons to dissect components involved in support
of peripheral motor axons. We will use biochemical and cellular complementation assays to examine LDHB
variants found in ALS patients and controls to determine if deleterious variants are enriched in ALS. We will
study mice lacking specific LDH isoforms in defined cell types to determine the cells involved in motor axon
metabolic support and the pathways they invoke to influence axon health. Additionally, we will use these LDH
mutant mice to interrogate how compromised lactate/pyruvate metabolism interacts with other ALS risk factors
to speed disease progression. Results of these studies will establish the relationship between LDH,
lactate/pyruvate metabolism in the PNS, and development of motor neuron diseases including ALS, and
stimulate development of new axo-protective therapeutics for these devastating disorders.

Public health relevance
Motor neuron diseases including Amyotrophic lateral sclerosis (ALS) involve loss of axons, including the essential connections between the spinal cord and muscles. Lactate metabolism plays an important role in nervous system health. We will explore findings that implicate abnormalities in lactate pathways in motor axon function and in progression of ALS disease symptoms, with a goal of developing new treatments for this disease.